HBCD Study Biospecimens Administrative Supplement: Resource Generation for Delivery Specimens

PROJECT SUMMARY/ABSTRACT
Opioid use during pregnancy is widespread and associated with adverse outcomes for both the pregnant
individual and the developing child. Prenatal opioid exposure is associated with a wide range of negative fetal
and child outcomes including reduced fetal growth, premature birth, lower birth weight, congenital defects,
increased neonatal healthcare, and heightened risk for later behavioral (e.g., anxiety, inattention), cognitive
(e.g., memory deficits, delayed language acquisition), and metabolic problems. Despite opioid use being linked
to adverse maternal, fetal, and child outcomes, the mechanisms through which these arise and the potential
consequences of prenatal opioid exposure for child health and development (e.g., brain and behavior) remain
largely unexplored. This lack of etiologic knowledge has contributed to stagnant treatment, prevention, and
mitigation efforts leaving individuals and families susceptible to reverberating adverse outcomes.
The HEALthy Brain and Child Development (HBCD) Study is a 25-site longitudinal prospective study of
early child development in the US that will assess a broad spectrum of biological (e.g., neuroimaging, genetics,
epigenetics), behavioral (e.g., cognition and emotional regulation), experiential (e.g., trauma), social (e.g.,
racism), and health (e.g., psychopathology) factors among ~7,500 nationally-representative pregnant women
and their children from pregnancy to mid-childhood. A major goal of the HBCD study is to increase
understanding of the potential consequences of prenatal substance exposures. The study population will be
enriched for maternal substance use during pregnancy (i.e., ~25% of the sample will have used opioids,
cannabis, alcohol, and/or tobacco during pregnancy and 12% of the total sample will have used opioids) and
offers a unique opportunity to inform our understanding of how the adverse consequences associated with
opioid use during pregnancy arise. Although HBCD will be the largest long-term study of early brain and child
development outcomes in the US, the core protocol does not include the collection of delivery biospecimens.
This Administrative Supplement in response to the NIDA/ORWH Administrative Supplement Notice of Special
Interests: HEAL Initiative: Biospecimen Collection in Pregnancy (NOT-DA-23-005) proposes to leverage the
HEALthy Brain and Child Development (HBCD) Study by expanding the biospecimen collection of the Core
HBCD Protocol to include delivery specimens (placenta, umbilical cord tissue, and cord blood). Delivery
samples will be collected from a representative sample of HBCD Study participants across up to 14 sites (and
over 2,000 participants across HBCD sites submitting applications in response to this NOSI). This will provide
an unprecedented resource-generating opportunity for the larger scientific community to comprehensively
evaluate pathophysiological mechanisms that mediate the connection between opioid and polysubstance use
during pregnancy and adverse neonatal, infant, child, and/or maternal health outcomes and, in turn, inform
innovative preventive strategies.

Public health relevance
PROJECT NARRATIVE This Administrative Supplement to a large national longitudinal pediatric study (HBCD) will expand biospecimen collection of the Core HBCD Protocol to include delivery specimens (placenta, umbilical cord tissue, and cord blood). This will provide an unprecedented resource-generating opportunity for the larger scientific community to comprehensively evaluate pathophysiological mechanisms that mediate opioid use during pregnancy and adverse neonatal, infant, child, and/or maternal health outcomes, and, in turn, inform innovative preventive strategies.